Leveraging mHealth to Promote Recovery from Opioid Use Disorder and Commonly Occurring Mental Health Disorders among Residents of a Medium-Sized Midwestern City

The overarching goal of this Research Scientist Development Award (K01) is to provide Dr. Hannah Szlyk with the training and research activities needed to become an independent researcher who develops, tests, and implements cutting-edge digital therapeutic interventions that can promote recovery from opioid use disorder (OUD) plus commonly occurring mental disorders (COMD). This application outlines an integrated training and research plan that will provide Dr. Szlyk with the skills needed to achieve her career goal. Under the mentorship of experts in clinical trials, addictions medicine, implementation science, user-centered design, and OUD research, Dr. Szlyk’s training will focus on the following key areas: (1) clinical trial methodology (Dr. Esther Lu; (2) implementation science and user-centered design (Drs. Patricia Cavazos-Rehg and Emily C. Williams); and (3) recovery from addictions and mental health (Dr. Darrell Hudson). Training in these three areas will be achieved through didactic and applied activities, participation in national conferences and institutes, and mentoring meetings. Dr. Szlyk will apply the skills acquired during the training activities to conduct a research project to appropriately adapt and test an mHealth intervention for residents of medium-sized midwestern cities with OUD plus COMD. Rates of opioid-related deaths continue to rise among residents of such communities in the United States, like St. Louis, Missouri, where this research is set. Yet, few interventions are developed to fit the unique needs of these clients; none address their heightened overdose risk often compounded by COMD which decreases likelihood for recovery success. Also, these clients experience significant barriers to life saving OUD treatments, like medication for OUD (MOUD). To address this gap, the K01 research project will integrate public health praxis, implementation science, and user-centered design strategies to appropriately adapt an mHealth intervention for residents of a medium-sized midwestern city with OUD plus COMD. The central hypothesis is that adaptations to the mHealth intervention will improve engagement and usability among participants, improve adherence to MOUD, and impact decreases in COMD. This research will address key gaps in treatment by 1) adapting an mHealth intervention for Individuals with OUD plus COMD; 2) identifying barriers and facilitators to implementing an mHealth intervention among stakeholders who serve clients with OUD plus COMD; 3) examining the preliminary efficacy of an adapted mHealth intervention. These data will inform the design of a larger RCT for a future R01 application. Dr. Szlyk’s training and proposed research will be carried out in the outstanding intellectual environment of Washington University School of Medicine, which will provide her with a multitude of resources to meet her goals.

Public health relevance
The opioid crisis has negatively impacted medium-sized midwestern cities in the United States in recent years, and this region continues to face significant barriers in access to appropriate treatment for opioid use disorder (OUD) and commonly occurring mental disorders (COMD). The current project will integrate public health praxis, implementation science and user-centered design approaches to understand how an mHealth intervention can be leveraged to support residents with OUD plus COMD. The preliminary efficacy of an adapted mHealth intervention will inform how this intervention can be further refined and scaled to provide care for OUD plus COMD and help to promote recovery among residents of medium-sized midwestern cities.